International Traineeships in AIDS Prevention Studies (ITAPS)

International Traineeships in AIDS Prevention Studies (ITAPS)
PROJECT SUMMARY/ABSTRACT
This renewal application for the International Traineeships in AIDS Prevention Studies (ITAPS) program,
University of California, San Francisco will promote global HIV prevention research by enhancing the capacity
of early-mid career investigators from low- and middle-income countries (LMIC) to publish their research and
learn to provide effective mentorship to others. The prevalence and incidence of HIV continue to be greatest in
LMIC, with infections rising for the first time in regions outside sub-Saharan Africa. ITAPS is a mature program
that has trained 447 scientists from 57 countries and led numerous in-country workshops; 87% of papers
initiated have been published. ITAPS has served as a catalyst for many to pursue further degrees, advance
professionally, continue to publish, and become leaders in their fields. Despite this success, further training of
scientists from regions with increasing HIV epidemics and focused on key populations are needed,
accompanied by local institutionalization of training. A large proportion of HIV research in LMIC continues to be
spearheaded by investigators from high-income countries who lead authorship; mentorship skills are not taught
or considered important. We will address these issues through our training. Applicants will be drawn from
global HIV research networks and institutions. Initial writing training will be zoom-based with small group
discussions to analyze data and produce scientific papers from publication in peer reviewed journals; regional
workshops will be held to ensure completion of papers; follow-up will continue until papers are published.
Mentors-in-training will participate in a zoom-based mentor skills workshop, support writing trainees, gain
experience teaching, and co- implement regional workshops. Both mentors and writing trainees will receive
guidance from ITAPS faculty throughout. New this cycle will be inclusion of training in AI literacy, greater
recruitment of trainees from regions with increasing HIV epidemics, and facilitating uptake of training and
mentorship by in-country institutions. We are unique in providing on-going one-one mentorship by faculty
leading to long term relationships and collaborations, and having a multiplicative impact on training LMIC
investigators. Aim 1. Provide research experiences and training for LMIC early-career investigators. We
will support 7 LMIC trainees/year to develop research questions based on the existing knowledge, and to write
and publish first-authored manuscripts. Aim 2. Provide mentorship activities for more advanced LMIC
investigators. We will support more advanced LMIC investigators (4/year, 20 total) to learn mentorship skills,
to apply these by supporting ITAPS trainees, and to advance mentorship at their institutions . Aim 3. To
implement regional workshops. We will implement 2 regional workshops/year for trainees to complete
manuscripts, provide further experience for mentors, and enhance the capacity of the hosting institutions.

Public health relevance
PROJECT NARRATIVE In this renewal application, the International Traineeship in AIDS Prevention Studies (ITAPS) at the University of California, San Francisco will enhance research capacity in lower and middle-income countries (LMIC) by enrolling early- career HIV investigators from LMIC who will engage in research experiences through training in manuscript writing and publication of first-authored papers; ITAPS will provide more advanced investigators with exposure to mentorship skills with practice supporting writing trainees; regional workshops will be implemented to ensure completion of papers, provide more experience for mentors-in- training, and facilitate uptake of training and mentorship by local institutions. ITAPS is unique in providing one-one mentoring that leads to long term relationships and collaborations, by acting as a catalyst for professional advancement of scholars and future publications, and in its multiplicative impact on the training. The program will increase the number of LMIC investigators who can address the epidemic in regions with rising incident HIV infections, who can evaluate bio-behavioral prevention and control programs in the local context, and address key populations and others at significant risk.